Optimizing c-Met signaling to enhance corneal epithelial homeostasis

Project Summary
The proposed research is relevant to public health because corneal blindness is the 4th leading cause of
blindness globally and is often preventable with proper healthcare. Blindness arises due to damaged integrity of
the corneal epithelium as the result of physical, chemical, or thermal trauma and/or as a consequence of
diseases, surgery, or anti-cancer drugs. Regardless of the cause, disruption of the epithelial layer is extremely
painful due to the dense sensory nerve innervation, makes the eye vulnerable to infection, and can result in
blindness. Despite the widespread incidence and the array of medical problems associated with epithelial
damage, there are no FDA-approved drugs that promote corneal wound healing or epithelial homeostasis. It is
well-established that proteins of the receptor tyrosine kinase (RTK) family can induce cell proliferation, migration,
survival, and differentiation of epithelial cells. We are investigating the signaling axis of one of these proteins, c-
Met, and its cognate ligand hepatocyte growth factor (HGF). c-Met activity can not only promote the wound
healing/re-epithelialization phenotypes stated previously but can also prevent transformation of keratocytes to
fibroblasts and promote neuronal growth. However, c-Met is limited for therapeutic reasons in that RTKs have
transient activation and are desensitized following ligand stimulation. We hypothesize that extending c-Met
receptor activity by disrupting its downregulation will help restore corneal homeostasis following
wounding. This hypothesis will be tested through the following aims: Aim 1: Determine if ubiquitylation of the c-
Met receptor limits its signaling in corneal epithelial cells in vitro. We hypothesize that inhibiting negative
regulation of c-Met signaling will prolong receptor activity and accelerate healing. We will test this by blocking c-
Met ubiquitylation in vitro by genetic knockout of CBL genes from immortalized human corneal epithelial cells
and measuring receptor phosphorylation, trafficking, in vitro wound healing, and cell migration and proliferation.
Aim 2: Determine effect of CBL knockout and c-Met activation in corneal wound healing murine models in vivo.
We hypothesize that HGF-induced c-Met signaling will not only aid in re-epithelialization, but also will decrease
fibrotic markers in the stromal layer and promote axonal outgrowth of corneal nerves. We will test this by using
corneal epithelial-specific, inducible CBL knockout murine models. We will wound the corneas and monitor gross
corneal morphology and homeostasis, re-epithelialization, fibrosis and inflammatory markers, and nerve
restoration. These studies are innovative because we will manipulate c-Met signaling regulation to extend
signaling and promote healing of all layers of the cornea. The proposed research is relevant to the National Eye
Institute’s mission of eliminating vision loss and improving quality of life through research.

Public health relevance
Project Narrative The proposed research is relevant to public health because the integrity of the corneal epithelium is frequently compromised as the result of trauma, surgery, side-effects of anti-cancer drugs, and as a complication of multiple diseases including diabetes and autoimmune disorders. Identifying the molecular mechanisms that regulate the integrity of the corneal epithelium is the first step in developing therapies that promote the homeostasis and regeneration of the corneal epithelium before vision becomes jeopardized. This project is relevant to the NEI’s mission to support research with respect to the molecular basis of visual function and the preservation of sight.